Role of Gut Microbiome- Brain Axis in Modulating CNS Inflammasomes in the Neuropathology Produced by Opioid Exposure and HIV

Abstract/Project Summary
Chronic opioid use is associated with gut microbial dysbiosis, gut barrier disruption and systemic bacterial
translocation. Gut leakiness, microbial translocation and systemic inflammation are hallmarks of HIV disease
progression. In recent years, much attention has been focused towards elucidating the impact of Toll-like
receptors (TLRs) in microglial activation and NLRP3 inflammasome assembly as a mechanism for sustained
neuroinflammation and neurocognitive disease progression. While previous studies have investigated the
direct effect of HIV associated toxic proteins (TAT and gp120) and opioids on inflammasome activation on
microglial little is known about the role of gut derived products and their impact on inflammasome activation
and neurocognitive disorders that are prevalent in substance using HIV patients. Although most studies
correlate endotoxin levels and bacterial products derived from gram-negative bacteria with inflammation and
HIV disease progression, recent studies clearly show a distinct enrichment and prevalence of gram positive
bacterial communities in HIV infected patients when compared to normal healthy individuals. Our central
hypothesis is that microbial dysbiosis with predominant expansion of Gram positive bacterial communities
leading to systemic leakage of G+ bacterial products serve as cognate ligands on TLR2 on microglial cells
leading to TLR2 activation and induction of inflammasome components assembly. Our central hypothesis is
supported by the following preliminary data. Using a rodent model of HIV in the context of drug abuse, we
demonstrate 1) Significant increase in a) gut bacterial translocation b) systemic inflammation c) NLRP3
expression on microglial cells in HIV infected animals that are dramatically exacerbated in HIV+ Morphine
treated animals when compared to their respective controls. 2) Morphine induced NLRP3 expression is only
observed in the presence of TLR2 cognate ligand in BV2 microglial cells. We will test the hypothesis that gut-
microbiota immune brain axis activate inflammasome signaling pathways in brain microglial cells leading to
sustained inflammation contributing to the neuropathology of HAND in an opioid abusing HIV infected patients.
Aim 1: We will establish the role of the gut microbiota in microglial inflammasome activation using a) germ free
mice b) differential antibiotic (gram specific depletion)treated mice and c) infection with gram positive
Enterococcus Faecalis. We will also investigate if sex of the animals serves as a biological variable in microglia
NLRP3 activation in our model of opioid dependence in the context of HIV infection. Aim 2: Determine the role
of TLR2 in NLRP3 induction in microglial cells using tissue specific deletion by breeding floxed TLR2 with
microglial specific cre expression using Cx3Cr1 Cre mice. Aim 3: Determine if combination of probiotics and
TLR2 antagonist attenuate NLRP3 induction on microglial cells.

Public health relevance
Project Narrative There is a strong correlation between chronic drug use and increase susceptibility to HIV infection. Chronic drug users accounts for approximately a third of all cases of AIDS in the USA and the progression to HAND is markedly accelerated in opiate drug abusers. This proposal postulates that modulation of microbiota by opioid drug abuse and HIV1 infection may be a plausible mechanism for inflammasome activation resulting in sustained inflammation and HAND progression these patients.